Neural and computational mechanisms of multi-option choice in prefrontal cortex

The goal of this proposal is to identify the computations and neural mechanisms for economic decisions
between many options, using a nonhuman primate model. Multi-option choices are ubiquitous in natural
settings but poorly understood. As a result, we lack basic knowledge of how the brain organizes real-world
appetitive behaviors or why these behaviors change in neuropsychiatric disease. The focus of the proposal is
how multiple options are compared, an essential computation that cannot be inferred from knowledge of
simpler two-option choices. We frame the studies in terms of a two-stage, integrate-to-threshold decision
mechanism: an input stage assigns values to each option, and an integration stage accumulates value signals
for each option up to a bound. Our overarching question is where and how the options are compared to each
other: at the input stage, at the integration stage, or both. Additionally, we seek to identify the functional form of
these comparisons and their capacity limits when many options are available. Because existing data and
models alone cannot answer these questions, we will use a tandem approach, first making cell-level
observations of neural activity in a nonhuman primate model of multi-option choice, and then using these
observations to constrain the specification of integrate-to-threshold models. In Aim 1, we record neural
populations in the primate ventromedial and orbital prefrontal cortex (vmPFC and OFC), two regions consistent
with the input stage in integrate-to-threshold models. The objective is to identify the broad class of functions
that neurons use to compare decision options, i.e., to assign a subjective value to a given option in relation to
the others available. In Aim 2, we identify the causal contribution of vmPFC and OFC to decision behavior,
using intracranial microstimulation to disrupt value-coding activity in each region. Aim 3 focuses on
comparisons at the level of integrated evidence using integrate-to-threshold models. Here we will fit a series of
models in which we constrain the value comparison functions used at the input stage and ask how these
constraints shape the strength of comparisons computed at the integration stage. Critically, a subset of these
models will assume input functions derived from the vmPFC and OFC recordings in Aim 1. By using brain-
derived constraints, these models are expected to give insights into integration mechanisms that could
plausibly be realized in neural circuits. At their conclusion, these studies will provide novel empirical evidence
showing how options are compared at early decision stages and new computational insights into how options
are compared at later stages. By using a nonhuman primate model and a naturalistic behavioral task, the
results are expected to have high translational potential. The proposed studies are innovative because they go
beyond the binary choice frameworks that dominate the field and will result in new models that can be used in
both monkeys and humans. And the findings are expected to be significant because they will provide new
knowledge of how the primate prefrontal cortex organizes a complex form of everyday decision-making.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because it focuses on the brain mechanisms of healthy decision-making, using innovative experimental and computational techniques to understand how the activity of neurons in the prefrontal cortex grants the ability to choose between multiple options. A better understanding of how the brain organizes healthy decision- making will provide opportunities to improve the diagnosis and treatment of conditions in which decision behavior is compromised, such as substance abuse, depression, eating disorders, OCD, and schizophrenia. The findings are therefore expected to be relevant to the part of NIH’s mission pertaining to behavioral and mental health, in particular the missions of NIMH and NIDA.